Environmental Influences on Child Health Outcomes in the Northern Plains Safe Passage Study Cohort

Project Summary/Abstract The overarching premise of this proposal is that the extant and proposed cohorts (n>4400), infrastructure, and investigative team of PASS-ECHO are uniquely poised to answer questions relating to the impact of prenatal and early childhood environmental exposures on later health outcomes. To accomplish this objective, the study will build upon the successful study infrastructure established through the Prenatal Alcohol in SIDS and Stillbirth (PASS) Network (NICHD U02-HD045935) and will utilize this unique cohort to provide a wealth of prenatal and infant data that can expand the capability of the ECHO study in areas of neurodevelopment, neurophysiology, and asthma, particularly among rural and American Indian youth. The PASS-ECHO investigative team has a proven track record in conducting complex and high quality studies while maintaining longitudinal participant and community engagement in the region. Complementary to the common protocol, the PASS-ECHO cohort will examine in-depth data concurrent to individual-, family-, and social-level factors .While this proposal focuses on neurodevelopmental and asthma outcomes, the PASS-ECHO cohort is capable of including additional measures to provide additional data for the other ECHO focus areas. The PASS-ECHO investigators, infrastructure, and cohort have the capacity to contribute significantly to meet the overarching goal of ECHO.

Public health relevance
Project Narrative The impact of this project is the unique inclusion of prenatal exposures by leveraging the extant cohort of the PASS study to investigate long-term neurodevelopment outcomes from rural and high-risk populations within the ECHO study. This study will include measures of fetal, infant, and child autonomic and neurophysiologic function as proximal outcomes, mediators, and predictors of later outcomes. This provides a platform for preventative prenatal approaches and innovation in postnatal interventions.